MODELING THE HIV EPIDEMIC

In this proposal we plan to develop procedures to estimate the unknown parameters and the numbers of infected people and to validate the stochastic models; we plan also to develop stochastic models and state space models for assessing effects of treatment by antiviral drugs and the development of drug resistance of HIV to these drugs. This proposal has four specific aims. Under Aim 1, we plan to develop longitudinal models for the treatment by antiviral drugs and the development of drug resistance. We will use the hierarchical Bayesian approach to estimate the parameters from regression coefficients; through an extended autoregressive time series model we will estimate the probability distribution of the time to the development of drug resistance of HIV to anti-viral drugs; we will assess effects of uncertainty of the distribution of time to HIV infection on the estimation results. We plan also to extend the results to models involving two or more drugs and to models involving two or more markers. Under Aims 2 and 3, we plan to develop a state space model for the dynamics of the immune response to HIV infection in the presence of treatment by antiviral drugs and the development of drug resistance of HIV to these drugs. We will compare results from different approaches and assess the usefulness of the statistical longitudinal models. Under Aims 3 and 4, by combining with the Kalman filter method we will develop procedures to estimate the dynamic parameters, the progression parameters as well as the numbers of HIV infected people. We will use both the frequentist's approach and the Bayesian approach and compare the results from these approaches.